Flow Of Gene Expression Across Mitochondrial Condensates

Project Summary/Abstract:
Phase transitions are emerging as a fundamental organizational principle for gene regulation.
Transcription is organized into diverse higher-order structures called transcriptional condensates:
Pol II associates into dynamic foci that rapidly assemble and disassemble concomitant with
mRNA production, while the nucleolus maintains a tri-partite layered structure that supports the
steady stream of rRNA. However, little is known how and why the flow of gene expression is
organized across disparate condensates in the mitochondria. For example, within the
mitochondrial matrix, the mitochondrial (mt-) genome and its RNA products are not diffuse but are
packaged by proteins into distinct droplet-like structures called mt-nucleoids or mtRNA granules,
respectively. Within the framework of biomolecular phase transitions, the vision of the research
program will be to investigate how biomolecules involved in mitochondrial gene regulation self-
organize into higher-order, functional structures in the mt-matrix and how anomalies to these
biophysical processes contribute to mitochondrial (dys)function. The goals for the next five years
are to identify the biomolecular interactions underlying the immiscibility of mt-condensates using
in vivo and in vitro systems and supported by theoretical modeling. Using super-resolution light
microscopy, we will perform biophysical experiments on the organization and dynamics of the
components within mt-condensates. We will complement these microscopy experiments with
next-generation sequencing approaches to identify the biomolecular networks underlying the
biophysical behavior. Next, using our established in vitro mt-transcriptional system, we will study
the interplay between phase coexistence and resulting transcriptional activity. We will support
these experiments by performing analogous perturbations in live cells within the phase transition
framework, allowing us to directly connect phase behavior to the flow of gene expression. Finally,
this proposal will elucidate how the structure-function relationships of mt-condensates contribute
to mitochondrial (dys)function in live cells. Overall, this research program will apply ideas from
thermodynamics and polymer physics to uncover the biophysical principles underlying the flow of
gene expression across these disparate condensates within the mt-matrix. This work will shed
light on the functional consequences of the canonical organization of mt-condensates and how
anomalies contribute to dysfunction, with implications for disease processes. By harnessing
mitochondrial biology, we will uncover structure-function relationships of transcriptional
condensates, which will pave the way for developing entirely new strategies to precisely target
these structures in the pursuit of improving human health.

Public health relevance
PROJECT NARRATIVE Gene expression is organized into diverse, droplet-like structures called transcriptional condensates in both the eukaryotic nucleus and the mitochondria. Here, in the context of biomolecular phase transitions, we will investigate how biomolecules–including the mitochondrial genome, its gene expression machinery and its RNA products–assemble and persist as disparate condensates within mitochondria. By studying the emergent structure-function relationships of mt- transcriptional condensates, we will determine the biophysical driving forces for the spatiotemporal organization of gene regulation in mitochondria and how anomalies contribute to mitochondrial (dys)function, with implications for human health.